Project 2: Splicing Dysregulation in Cancer

PROJECT 2 – RNA-SPLICING DYSREGULATION IN CANCER
PROJECT SUMMARY
The overarching goal of Project 2 is to understand the various roles of alternative splicing in pancreatic and
breast cancer, and to exploit cancer-specific features of this process to develop targeted-therapeutic
approaches. Cancer cells display extensive qualitative and quantitative dysregulation of splicing, and a subset
of the isoforms that are inappropriately expressed contribute to tumorigenesis or altered cell metabolism. The
mechanisms and pathways through which the splicing-factor oncoprotein SRSF1 accelerates transformation of
pancreas ductal cells, and its reciprocal regulation with mutant KRAS, will be investigated. The spliceosomal
core component BCAS2 will be studied to understand the impact of its elevated expression on alternative splicing
and tumorigenesis in pancreatic and breast cancers. Organoid models, as well as orthotopic and genetic mouse
models, will be used to study tumorigenesis promoted by these splicing factors when their expression is elevated
in pancreatic or breast cancer, with an emphasis on basal-like subtypes. High-throughput RNA-sequencing and
computational analyses will be employed to identify and compare the affected splicing targets of SRSF1 and
BCAS2 in these different cancer contexts, and selected target isoforms will be characterized and manipulated to
evaluate their contributions to tumorigenesis and potential as therapeutic targets. One key event, alternative
splicing of pyruvate kinase M pre-mRNA, which controls the distinctive glycolytic metabolism of cancer cells, will
be thoroughly investigated as a potential therapeutic target, by specifically manipulating this process in vitro and
in vivo, using antisense technology and organoid and mouse models of pancreatic and breast cancer.

Public health relevance
PROJECT 2 – RNA-SPLICING DYSREGULATION IN CANCER PROJECT NARRATIVE RNA splicing is a fundamental step in the normal function of genes. In cancer cells, this process is altered in ways that can contribute to tumor growth. By studying dysregulated splicing in cancer, unique vulnerabilities of cancer cells will be uncovered, and potential therapeutic targets revealed.